UAB Pilot Center for Precision Animal Modeling (C-PAM)

ABSTRACT (OVERALL)
With the rapid increase in the number of potential variants being identified through whole genome sequencing
technologies in patients with rare disorders, the challenge for geneticists is now to confirm that these variants
are causative of the phenotype. This requires detailed assessment and annotation to separate the causative
variant from those that are simple nonsignificant polymorphisms and sequencing or mapping errors. This is a
complex problem to address requiring interdisciplinary approaches, detailed bioinformatic analysis, the
generation of informative animal models, and a concerted effort to evaluate the variants. Accomplishing this goal
is frequently beyond what an individual lab can easily or efficiently accomplish. In this regard, the Center for
Clinical and Translational Science and the Precision Medicine Institute assembled a team of scientists and
clinicians with expertise in basic research, computational and data sciences, human genetics, clinical diagnosis,
and animal model generation to form the UAB Center for Precision Animal Modeling (C-PAM). The team has
established a pipeline in which research and clinical community nominated variants will be thoroughly analyzed
using an innovative bioinformatic toolkit generated by the C-PAM Bioinformatics Section. Selected variants will
be modeled in animals by the C-PAM Disease Modeling Unit and the new models evaluated for human disease
relevance by clinicians in the C-PAM Pre/Co-clinical Section. Once generated, C-PAM established collaborations
will utilize the detailed informatic analyses and the animal resource that will be distributed through the C-PAM
Resource and Services Section to advance our understanding of disease pathogenesis, to ascertain efficacy of
novel or repurposed therapeutics, and to contribute to improved human health. C-PAM will leverage and organize
our already existing expertise to fulfill our vision to become a national resource for efficient and cost-effective
analysis of pathogenicity of gene variants identified in patients with rare disorders and to produce informative
animal models to pursue disease mechanisms and targeted therapeutics.

Public health relevance
PROJECT NARRATIVE (OVERALL) Every undiagnosed disease program faces a huge problem of having identified significant numbers of genomic variants with insufficient functional evidence for clinical reporting and thus lacking clinical actionability. The UAB Center for Precision Animal Modeling (C-PAM) will develop a strategy and pipeline for efficient modeling and analysis of genomic variants of uncertain significance that are associated with a disease to determine if the variant is causal of the disease, to evaluate the significance on gene function and disease pathophysiology, and to support identification and evaluation of therapeutic targets. C-PAM will accomplish this by analyzing variants using a series of rigorous clinical and innovative bioinformatic tools and through the generation and distribution of clinically and molecular informative animal models to the research community.